Accurate Molecular Decision Making during Protein Biogenesis

Project Summery
Equipment supplement – same as the parent grant

Public health relevance
Narrative Equipment supplement – same as the parent grant